Theory and Modeling of Biomolecules and their Interactions

Project Summary/Abstract
The establishment of tools and methods from statistical mechanics and computer simulation technology to
enable the exploration of biological molecules and their interactions plays a central role in discovery within
biomedical research. This proposal represents a request for support of our ongoing efforts in this area and
includes objectives to address challenges in the theory and modeling associated with these problems, as well
as strategically chosen collaborations that will help elucidate important biomedical questions and provide crucial
tests of the approaches we develop. Our proposed development efforts include the exploration of receptor-ligand
interactions and the thermodynamics of ligand binding to biological receptors through the continued development
and application of novel methods of free energy simulations to ligand binding thermodynamics, docking and
receptor-ligand interaction modeling. The continued refinement, hardening and application of theoretical and
computational methods of constant pH molecular dynamics to integrate the critical aspects of pH and protonation
state changes in protein and nucleic acid receptors and their ligands in molecular simulations and modeling
represents another challenge we will continue to address with the proposed work. Finally, software
infrastructure, specifically the CHARMM macromolecular simulation package, provides the framework for
advancing our methodological approaches and enabling the broader community to explore biomedically
motivated questions via its wide usage and distribution. A component of our proposed efforts will be to continue
the innovative implementation of methods and simulation approaches into this community standard software
package. We will balance and drive our development efforts in the areas of free energy simulations, ligand –
receptor docking and pH-mediated structure-function processes, important to a deeper mechanistic
understanding of biomedically directed questions, through strategic collaborations with experimental colleagues
in the areas of: transcriptional activation based on small amphipathic molecules targeting co-activators from the
CREB binding protein (KIX) and the AciD domain of Med25; kinases with a specific focus on discovering sites
for allosteric control of conformational changes and the discovery and design of ligands to control these
dynamics; enzyme redesign and substrate scope expansion to better understand the evolution of function of a
novel Flavin-dependent hydroxylase in exploiting complex chemical transformations important in the
development of pharmaceuticals; the pH-modulated switch for myristoylated histactophilin, the actin binding
protein that is structurally homologous with interleukin-1b and fibroblast growth factor. Finally, we will engage
experts in the development of improved sampling methods for ligand-binding free energy calculations and big
data applications of molecular simulations and the design and execution of robust user APIs to work with us
toward advancing objectives in software development for automated workflows, through pyCHARMM, for
sophisticated simulation protocols.

Public health relevance
Relevance The goal of this research effort is to develop novel and versatile methods to study via computer simulation biological molecules and their interactions with specific focus on methods for small molecule (drug-like) interactions with their biological receptors and pH-dependent mediation of biomedically important processes. Using a multidisciplinary approach, improvements in theory and methods will be tested through strategic biomedical applications with experimental collaborators and new insights into fundamental biomedical questions relating transcription, cancer and signaling will be addressed.